Tofacitinib Analogs as Oxacillin Potentiators against MRSA

Project Summary
Methicillin (oxacillin)-resistant Staphylococcus aureus (MRSA) infections are among the most frequently
occurring and dangerous antibiotic-resistant public health threat. Clinical resistance to all front-line MRSA
antibiotics (i.e. vancomycin, linezolid, daptomycin, and ceftaroline) has been observed, further exacerbating
this threat and highlighting the urgent need for new strategies to overcome drug resistance in S. aureus. In
recent years, there has been increased interest in targeting signal transduction systems for development as
antimicrobials and anti-virulence agents. Targeting bacterial signal transduction is attractive because these
systems are essential for many cellular processes in prokaryotes, and signal transduction pathways have been
extensively studied in eukaryotic systems, as evidenced by the availability of chemical libraries containing
small molecule probes with kinase inhibitor-like properties. With this strategy in mind, we screened a focused
set of kinase inhibitors and identified tofacitinib, an antirheumatic Janus kinase inhibitor, as a potential
chemistry starting point for the discovery of beta-lactam potentiators against MRSA. Several pyrrolopyridin-4-
amine (P4A) analogs of tofacitinib were synthesized, which led to the discovery of potent analogs with the
ability to re-sensitize oxacillin (OXA; a beta-lactam antibiotic) against MRSA. Preliminary pull-down proteomic
experiments have identified PurM, SrrB, and PknB as putative targets, studies that have been complemented
by gene knockout experiments. Therefore, the main scientific objective of this proposal is to confirm P4A
engagement of putative targets using biophysical and biochemical techniques and to establish the
therapeutic potential of tofacitinib analogs as anti-virulence agents and OXA potentiators against
MRSA. In Aim 1, I will evaluate the binding of lead P4A compounds to putative targets, demonstrate inhibition
of S. aureus kinase activity and determine the extent of potential off-target effects on mammalian kinases.
Biophysical assays will be developed against the putative targets through a novel target engagement assay,
which will be complemented with biochemical phosphorylation and ATP/ADP conversion assays. In Aim 2, I
will evaluate the clinical potential of the P4A compounds through anti-biofilm studies, pharmacological ADME
profiling, and in vivo efficacy against MRSA in a mouse model. The research plan will enhance my training in
areas of target identification and validation, biophysical analysis, and anti-infective microbiology, benefiting
from the expertise of my co-mentors, Drs. Richard Lee and Jason Rosch, and the state-of-the-art resources at
St. Jude.

Public health relevance
PROJECT NARRATIVE: Clinical resistance to all front-line antibiotics used to treat methicillin-resistant Staphylococcus aureus (MRSA) has been observed, highlighting the urgent need for new strategies to overcome drug resistance. Previous work by our group has identified tofacitinib analogs as beta-lactam potentiators against MRSA and have identified PurM, SrrB, and PknB as their putative molecular targets. Our current work will demonstrate target engagement and will establish their therapeutic potential in vivo.